Extracellular Matrix and Outflow Resistance

Project Summary
Elevated intraocular pressure (IOP) is a primary risk factor for glaucoma, which affects over 66 million people
worldwide. Lowering IOP remains the only effective therapeutic strategy to stop the progression of glaucomatous
vision loss. The trabecular meshwork (TM) is the primary site of IOP regulation, but few outflow drugs specifically
target the TM, the site of pathology. The newest class of glaucoma drugs, Rho kinase inhibitors, inhibit the Rho-
ROCK pathway to disassemble actin stress fibers. However, recent studies failed to detect stress fibers in human
ex vivo TM tissue. Thus, the exact biological mechanisms of how Rho kinase inhibitors lower IOP remain unclear.
Instead, cortical actin networks predominate in situ. Since Rho GTPases regulate cortical actin, Rho kinase
inhibitors may target cortical actin. This is an unexplored research avenue in the TM. Contractility of cortical
actin, which sits just beneath the cell membrane, exerts tension and produces a mechanical force that drives
changes in cell shape such as invaginations and cellular protrusions. In this application, we will focus on the
relationship between cortical actin, the plasma membrane and ECM as it pertains to two TM cellular protrusions:
filopodia/tunneling nanotubes (TNTs) and podosome and invadopodia-like structures (PILS). We will investigate
whether the `picket-fence' model of membrane organization influences filopodia/TNTs. In this model, the
membrane is compartmentalized by transmembrane `picket' proteins, e.g. CD44, which are anchored
extracellularly and to sub-membrane intracellular “fences” (cortical actin). `Picket-fence' molecules `corral' other
transmembrane proteins, such as integrins, into membrane compartments. In Aim #1, we will test whether
manipulation of actin-binding proteins and/or CD44 `picket' proteins will lead to local disassembly of the cortical
actin `fence' to initiate TNT formation. Effects will be determined by super-resolution confocal microscopy, TNT
vesicle transfer assays, live TM cell imaging and CD44 phosphorylation assays. The effects of specific actin-
binding protein inhibitors on outflow regulation in perfusion culture will be investigated to evaluate their potential
to modulate IOP. Aim #2 will investigate plasma membrane tension and integrin activation in normal and
glaucomatous TM cells. Differences in cell membrane tension will be measured using a Flipper-TR fluorogenic
probe and integrin activation state will be determined using conformation-specific antibodies. This will provide
novel information on how membrane tension influences transmembrane receptor activation. Finally, in Aim #3,
we will investigate Myosin-X, an actin-binding protein that is a component of PILS. We will investigate the role of
Myo10 in coordinating integrins and matrix metalloproteinase activity at these degradative complexes in TM cells
at rest and when subjected to mechanical stretch, and in TM tissue of human anterior segments perfused at 1x
and 2x pressure. Understanding the molecular machinery influencing cellular protrusions (filopodia/TNTs and
PILS) will provide novel insights into the role of the cortical actin cytoskeleton in IOP regulation, will revise our
current understanding of how Rho kinase inhibitors lower IOP and may lead to new glaucoma therapies.

Public health relevance
Project Narrative Glaucoma is a leading source of vision loss worldwide and is frequently associated with elevated intraocular pressure (IOP). This study aims to investigate the actin cytoskeleton and extracellular matrix of normal and glaucomatous trabecular meshwork cells at two dynamic cellular structures important for regulating IOP. Results may provide new information about how normal eyes regulate IOP, while providing new avenues to explore to develop novel therapies to reduce elevated pressure in glaucoma patients.